Mouse Exercise and Metabolic Phenotyping Core

ABSTRACT
The Mouse Exercise and Metabolic Phenotyping Core (Core B) will facilitate the design and execution of
the exercise experiments for Program Project members. Core B leverages the facilities and infrastructure of an
original NIH-funded Mouse Metabolic Phenotyping Center (MMPC, www.mmpc.org) at Vanderbilt University
and the specific expertise of its Director, David Wasserman, PhD in exercise physiology. Core B has already
designed and executed exercise studies that have been recently published by the Elmquist, Zigman and
Williams laboratories, in addition to designing all of the exercise paradigms used to generate the respective
preliminary data for the current application. (see publications section within the individual projects).
Core B will provide the following Exercise Protocols and Measurements:
Exercise Protocols
 Incremental treadmill exercise test to assess peak O2 uptake and work capacity
 Analysis of endurance capacity utilizing motorized treadmills
 Perform acute high intensity interval exercise
 Perform chronic exercise training
Measurements
 O2 uptake, CO2 output, and respiratory exchange ratio (RER) will be measured during or after exercise
 Body mass and composition
 Blood sampling through an indwelling catheter
 Analysis of liver and skeletal muscle glycogen content
 Analysis of biochemical signaling pathways
 Analysis plasma analysis of insulin, ghrelin, glucagon, triglycerides (TG), and non-esterified fatty acids
(NEFA)

Public health relevance
NARRATIVE The Mouse Exercise and Metabolic Phenotyping Core (Core B) serves a central role with respect to facilitating exercise treadmill experiments. Core B will also be an essential component of post-exercise metabolic phenotyping of the mouse models proposed by all 3 projects. The Core will be centralized within the Vanderbilt Mouse Metabolic Phenotyping Core and oversee exercise protocols at UTSW and UPenn. Centralized Core services provide procedural consistency, are more cost effective, and make technically challenging assays available to all investigators.